Defining vibrio cholerae virulence circuitry using bioinformatics and genetics

DESCRIPTION (provided by applicant): PUBLIC HEALTH RELEVANCE:

Public health relevance
Vibrio cholerae has figured prominently in the history of infectious diseases as a cause of periodic global epidemics. Cholera still occurs widely. This study proposed will shed light on importance of V. cholerae’s virulence gene regulations in host-pathogen interactions, with the goal of better understanding V. cholerae pathogenesis and, potentially, discovering novel treatment options for the cholera disease.